Systems-Level Research in Microbial Pathogenesis

PROJECT SUMMARY
This training program in “Systems-Level Research in Microbial Pathogenesis” will formalize and strengthen
interdisciplinary research in microbial pathogenesis and high-throughput science that interrogates parasites,
fungi, bacteria, and viruses more completely at the systems-level. The University of Maryland Baltimore has
exceptional strength and depth in microbiology, infectious disease, vaccinology, genomics, and bioinformatics
with >100 faculty with research in these areas. The nineteen senior training faculty and seven junior training
faculty are drawn from the world class microbial pathogenesis research programs in the Schools of Medicine,
Dentistry, and Pharmacy; including scientists from two of the university's internationally renowned research
institutes—the Center for Vaccine Development and the Institute for Genome Sciences. These faculty have
>1000 publications in the past ten years and 93 grants with average direct costs of $1,707,495/year. They will
develop and participate in a new graduate course targeting these trainees that is aimed at interdisciplinary
research at the intersection of microbial pathogenesis and systems-level research. Predoctoral trainees will be
selected from two interdepartmental doctoral programs that include a common core curriculum, elective
courses, journal clubs, seminars, annual symposia, and graduate research presentations. The selected
predoctoral students will also include trainees from the School of Medicine MD/PhD program and the School of
Dentistry DDS/PhD program. Academic work will be combined with rigorous mentored research training in the
research groups of the training faculty, who have current and past training grant eligible predoctoral trainees
with an average of 4.0 publications/trainee. Postdoctoral trainees will be selected through recruitment of new
fellows to the University of Maryland Baltimore. Our training grant eligible postdoctoral trainees have been
equally productive with 4.5 publications/trainee. The program is guided by a highly qualified team of three Co-
Directors (MPIs) with two serving as track leaders, as well as an internal Executive Committee. An External
Advisory Committee has also been established that will evaluate the program. Our trainees will be further
focused on systems-level research in microbial pathogenesis through a change in our curriculum, as well as
unique opportunities that will aid in recruitment and development of more students in this area. Programs that
distinguish trainees from the larger pool of graduate students, to promote and enhance their training, include (i)
oral presentations at the annual University of Maryland intercampus Crosstalk symposium, (ii) regular training
program research meetings, (iii) teaching opportunities in graduate and medical courses, (iv) opportunities to
present at national or international conferences, (v) opportunities to present in internal seminar series, (vi)
formalized career mentoring and career-focused networking, and (vii) formal training in mentorship and
mentoring an undergraduate or high school student from groups typically underrepresented in science, helping
to build our robust pipeline for developing diverse scientists.

Public health relevance
NARRATIVE Our future ability to fight infectious disease depends on advanced training of students so that they gain the analytical skills needed to investigate these diseases in ways that emphasize the complexities of interactions between the pathogen, host, and microbiome. Our trainees will receive exceptional academic mentoring and professional development training from our dedicated, highly experienced, and accomplished faculty working in this area. This includes diverse trainers and trainees and will include activities where trainees mentor the next generation of scientists from populations typically underrepresented in science.